George M. O'Brien Kidney Center at Yale

Center Project Summary/Abstract This is an application for renewal of the George M. O'Brien Kidney Center
at Yale. This center was established with the overarching goal to facilitate basic, translational and clinical
research that will advance the prevention and treatment of kidney diseases. Major research areas of emphasis
are epithelial cell biology and renal physiology; inherited kidney disease and kidney development; acute kidney
injury (AKI) and chronic kidney disease (CKD); and vascular biology, inflammation and glomerular disease. A
critically important benefit of the Center is to provide renal investigators both at Yale and across the country
with access to highly specialized services not otherwise routinely available to support their research. To this
end, the Center includes three Biomedical Research Cores. The Animal Physiology and Phenotyping Core
(Core A) provides specialized services and training for assessing renal function and blood pressure regulation
in small animals. Its services include clearance studies in anesthetized animals, perfusion fixation for histology
studies, serum and urine electrolyte values, acid-base parameters, serum and urine creatinine, balance studies
in metabolic cages, acute blood pressure measurements in anesthetized mice, and chronic awake blood
pressure measurements by radiotelemetry. The Disease Models and Mechanisms Core (Core B) provides
users with ready access to unique mouse models, associated cell line resources, and advanced human
translational technologies. Its services include bacterial artificial chromosome (BAC) recombineering and
transgenesis, support for CRISPR/Cas9 genome editing for mouse line production, support for kidney cell line
production by genome editing or from mutant mice, and support for targeted protein-based interrogation of
human urine and kidney biopsy samples. The Human Genetics and Clinical Research Core (Core C) provides
services and training to enhance translational studies in kidney disease. Initially established to facilitate
genetics studies, its services include patient DNA extraction and archiving, tools for high throughput SNP
genotyping and DNA sequencing, analysis of genetic linkage and linkage disequilibrium, and whole exome
capture and sequencing. Its services have been expanded to now facilitate translational research beyond
genetics, including support for protocol development, patient recruitment, sample processing, biobanking,
multiplex assays for biomarkers, and biostatistical and epidemiological support. Our cores currently have a
combined user base of >145 investigators, including >90 at outside institutions. A Pilot and Feasibility Program
has the goals of providing initial project funding for young investigators, attracting new investigators into the
field of kidney disease research, and fostering translational and clinical studies directly related to kidney
diseases. In addition, an Enrichment Program enhances kidney disease research by maximizing interaction
and information sharing among renal investigators and trainees, and by providing activities to enhance
recruitment and education of all levels of trainees from undergraduate students to postdoctoral fellows.

Public health relevance
Center Project Narrative The goal of the Yale O'Brien Center is to facilitate research that will advance the prevention and treatment of kidney diseases. To achieve this goal, the Center operates core facilities to provide investigators with access to specialized services not otherwise routinely available to support their kidney research. The Center also provides a pilot grant program, and coordinates an enrichment program of training and educational activities.